Chondronoids for Studying Collagen-II Homeostasis and Diseases

PROJECT SUMMARY/ABSTRACT
Type II collagenopathies are a class of disease caused by mutations in collagen-II, the most
abundant protein in cartilage. These diseases present with various symptoms affecting joint structure,
cartilage properties, and skeletal development. Currently, they have no cure. Patients rely on palliative
treatments as their symptoms arise. Two examples are the chondrodysplasias caused by mutations in
COL2A1 leading to either the G1170S or R719C substitutions in collagen-II. Patients present with one
or more of the following symptoms: precocious osteoarthritis, avascular necrosis of the femoral head,
and Legg-Calvé-Perthes disease. Previous cell and mouse models hindered research on these
diseases owing to poor recapitulation of the human phenotype, and poor adaptability for the necessary
molecular biology and biochemical assays required to understand molecular origins of the disorders.
In the absence of amenable models to probe the effect of collagen-II misfolding on cells and tissues,
progress on identifying therapeutic targets and novel treatment options remains slow.
These challenges can be overcome by using a panel of induced pluripotent stem cell (iPSC)
lines capable of being differentiated into cartilage-producing chondrocytes to elucidate the underlying
collagen production and misfolding defects. Harnessing a panel of previously generated gene-edited,
genetically matched iPSCs harboring the G1170S and R719C collagen-II mutations and wild-type
control, the underpinnings of the disease can be examined in vitro with unprecedented resolution. This
highly pertinent system will help illuminate the biochemical manifestations of disease-causing collagen-
II mutations at tissue, cellular, and protein levels. Thanks to outstanding facilities and experts at MIT,
training will include a wide variety of broadly useful techniques such as proteomics, RNA-sequencing,
stem cell culture, and organoid generation to examine characteristics such as matrix composition and
structure, collagen stability, and activation of stress pathways. At the molecular-level, state-of-the-art
mass spectrometry and biochemical assays will enable investigation of the interactions required for
wild-type and misfolding-prone collagen-II to assemble, fold, and be secreted. This approach based in
a highly relevant model will elucidate how the wild-type protein folds, while also probing the specific
molecular causes of pathology by harnessing a hypothesis-driven, direct investigation of how mutant
collagen-II misfolds and diverges from the normal proteostasis pathways. Overall, this research is
expected to make a considerable contribution to our understanding of collagen-II homeostasis in health
and disease, and to lay a strong foundation for identifying novel therapeutic targets to solve the collagen
misfolding problem in this and potentially the many other related collagenopathies.

Public health relevance
PROJECT NARRATIVE Mutations in the collagen-II gene lead to an array of chondrodysplasias that affect skeletal development and cartilage properties. Current treatments are palliative, and make no attempt to address the underlying, causative protein misfolding problem. This project proposes to harness a novel chondronoid model to delve into the molecular underpinnings of the cartilage pathology caused by a panel of collagen-II mutations as a means to gain insight into collagen-II proteostasis, its breakdown in disease, and novel therapeutic targets to potentially treat this class of disease.